Development of Spatial Transcriptomics Capability

The goals of the Nebraska Center for Molecular Target Discovery and Development (CMTDD) are to (1)
provide the means necessary to define, validate, and develop potential therapies against disease targets, and
(2) facilitate the professional and scientific development of early-stage investigators. Consistent with the scope
of the CMTDD mission, the aim of this supplemental request is to purchase a MERSCOPE (Vizgen, Inc.) and
provide spatial transcriptomics capability to early-stage investigators of the Nebraska Center for Molecular
Target Discovery and Development (CMTDD) and other COBREs in the University system. MERSCOPE will
be a cornerstone of the CMTDD omics resource, which will lower the cost barrier for investigators whose
research papers and grant applications would benefit from the generation and analysis of complex data sets.

Public health relevance
Project Narrative The Nebraska Center for Molecular Target Discovery and Development (CMTDD) requests funds for the purchase of new technology (MERSCOPE, Vizgen, Inc.) for the detection and quantification of gene expression in tissues and organs. MERSCOPE will provided the faculty of the University of Nebraska Medical Center (UNMC) and the University of Nebraska system with a powerful experimental tool with which to address complex biological questions and generate sophisticated data set that will enhance the impact of their scientific publications and enhance the competitiveness of their research grant proposals. Consistent with CMTTD goals, this new technology will facilitate career advancement of promising new faculty and help drive drug target discovery and development to benefit human health in Nebraska and the nation.